PREDIAGNOSTIC BREAST CANCER SERUM BANK (COLUMBIA, MISSOURI)

DISCONTINUED The objective of this serum bank is to provide a mechanism for prospectively evaluating relations of serum concentrations of various analytes such as hormones, antioxidant micronutrients, vitamin D, and environmental pollutants, with breast cancer risk. BACKGROUND: The serum bank was created as part of NCIs Biological Markers Project. Between 1977 and1987, a total of 7,355 women free of breast cancer donated blood to the bank, and by the end of followup in 1989, 146 of these women had been diagnosed with breast cancer. Questionnaires that ascertained information on age, height, weight, reproductive history, medical history, medications (including exogenous estrogens), and family history of breast cancer were completed at each blood collection. Serum has been stored at -70? C since it was collected. METHODS: The serum bank has been used for nested case-control studies of breast cancer in relation to sex hormones, antioxidant micronutrients, pesticides, and PCBs. PROGRESS: We reported strong positive associations of bioavailable estradiol, testosterone, DHEA, and androstenediol with postmenopausal breast cancer. Additionally, data suggested inverse associations for the carotenoids, lycopene, lutein/zeaxanthin and beta-cryptoxanthin with risk. No association was observed for pesticides and PCBs with breast cancer. Laboratory assays of vitamin D and additional sex hormones have been completed and data analysis is underway. A pilot study for an extended follow-up of participants through 1999 has been approved and will be initiated in the spring of 1999. - breast cancer, hormones, Epidemiology, nutrition, - Human Subjects: Interview, Questionaires, or Surveys Only & Human Tissues, Fluids, Cells, etc.